Combining Positive Deviance and Implementation Science to Improve Retention in HIV Care in South Africa

PROJECT SUMMARY/ABSTRACT
Despite notable increases in antiretroviral therapy (ART) adherence and decreases in mortality, South Africa is
not close to achieving the UNAIDS goals of 90% of all people living with HIV (PLWH) diagnosed, 90% of those
with a positive HIV diagnosis on antiretroviral therapy (ART), and 90% of those on ART with undetectable HIV
RNA by 2020, with only 60% of all PLWH having undetectable RNA as of 2017. Moreover, in the Western
Cape, the viral load suppression (VLS) rate (54.7%) is the second lowest in the country, and the average 6-
month rate for retaining PLWH in primary health care clinics is 64%. Retention is critical for improving ART
adherence and VLS. Clinics face myriad challenges retaining PLWH in care long enough to maintain VLS.
Structural-, organizational-, and individual-level patient barriers impede retention. Nevertheless, a handful
(about 8%) of health care clinics consistently have retention rates at 80% or above. Information about how
these clinics manage to succeed despite pervasive barriers could help improve retention rates in clinics that
are not performing as well. Positive Deviance (PD) is an approach to studying ways in which a minority of
individuals or organizations succeed despite barriers that typically hinder success. The approach begins with a
“discover” phase in which intensive study is undertaken to uncover unique strategies of clinics with better
outcomes than those facing similar challenges, followed by an implementation phase in which the strategies
are implemented. In a collaboration among the RAND Corporation, the South African Human Science
Research Council, and the South African Western Cape Department of Health, we propose (1) to use a PD
approach and mixed methods research (a provider survey that assesses contextual factors thought to be
associated with performance; patient shadowing; semi-structured interviews with clinic leaders, and focus
groups with providers and patients) to discover strategies used by primary health care clinics that retain 80% or
more of PLWH in care; (2) to develop an intervention that consists of a toolkit with novel PD strategies
identified in Phase 1 and implementation science methods for successfully implementing strategies; and (3) to
implement the PD intervention in 3 low-performing pilot clinics and conduct a pilot cluster randomized trial to
evaluate (a) feasibility (extent to which the PD strategies are implemented); (b) acceptability (clinic staff
attitudes about the toolkit, the strategies, and implementation processes); and (c) preliminary effects of the
intervention on PLWH retention in care and VLS. To determine feasibility, we will collect attendance logs and
activity worksheets; to assess acceptability, we will conduct focus groups with providers and patients; to
assess preliminary effectiveness, we will examine changes in patient retention and VLS at intervention clinics
from 6-months before the intervention and during the intervention period, compared to changes in all other low-
performing clinics. The proposed study would be the first to experimentally test a PD intervention to improve
retention in HIV care for PLWH; if effective, it could lead to higher retention and VLS rates and lower mortality.

Public health relevance
PROJECT NARRATIVE/RELEVANCE Retaining people living with HIV in care in primary health care clinics in the Western Cape (WC) of South Africa, a region with high HIV prevalence and the second lowest viral load suppression (VLS) rates in the country, is an ongoing challenge. Retention is associated with greater antiretroviral therapy adherence and VLS, but clinics in the WC only retain an average of 64% of patients who begin treatment. The proposed study will combine a Positive Deviance approach with implementation science methods to identify clinics in the WC with retention rates above 80% (currently 8% of all clinics have achieved this), employ quantitative and intensive qualitative methods to discover unique strategies that might be contributing to high retention rates, and develop and implement in the lowest performing clinics a novel, clinic-level intervention to test feasibility, acceptability and preliminary effects on retention and VLS; if effective, the intervention ultimately could lead to greater retention and VLS and lower mortality in the region and elsewhere.